DO LEUKOCYTES NEED TO BE SEPARATED FROM WHOLE BLOOD FOR CYSTINE LEVELS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Evaluate how storage time and storage temperature of whole blood samples affect white blood cell cystine levels